Caring Contacts via text message for suicidal adolescents after emergency department discharge

Project Summary (Abstract)
The purpose of this Mentored Patient-Oriented Research Career Development Award is to prepare Jennifer
Hoffmann, MD, MS, a pediatric emergency medicine physician, for a career as an independent clinician-
investigator focused on adapting and implementing evidence-based mental health interventions for youth in the
emergency department (ED) setting, with a particular goal of reducing youth suicide attempts and deaths. This
proposal includes intensive mentorship, training, and research activities that will enable Dr. Hoffmann to build
on her existing strong foundation in health services and outcomes research to: (1) acquire experience with
user-centered design, (2) become an expert in implementation science, including conducting hybrid
effectiveness-implementation studies, and (3) develop expertise in ED-based digital mental health
interventions. Suicide is the third leading cause of death in adolescents in the United States, and ED visits by
youth for suicidal thoughts and behaviors have increased over the last decade. The ED represents a critical
contact point to detect suicide risk and initiate preventive interventions. Youth who visit the ED for suicidal
thoughts or behaviors remain at high risk after discharge, with as many as 22% attempting suicide within one
year. Thus, effective interventions are needed for the high-risk period following ED discharge. Caring Contacts
are brief, supportive messages that have been shown to prevent suicide attempts and suicides among adults
after inpatient psychiatric hospitalizations or ED visits, but there has been limited evaluation of Caring Contacts
for adolescents. The objective of this proposal is to adapt and implement Caring Contacts delivered via text
message to adolescents with suicidal thoughts or behaviors following discharge from the ED. To do so, Dr.
Hoffmann will pursue the following specific aims: (1) adapt Caring Contacts delivered via text message to align
with adolescent preferences, (2) develop a multicomponent implementation strategy for delivery of Caring
Contacts via text message for adolescents following an ED visit for suicidal thoughts or behaviors, and (3) pilot
Caring Contacts via text message to assess feasibility, acceptability, and preliminary intervention effectiveness
and implementation outcomes. Results will provide the data necessary for a planned R01 that is a full-scale
hybrid effectiveness-implementation type II study of Caring Contacts for adolescents. The proposal is closely
aligned with the National Institute of Mental Health Strategic Priority 3.2.A, “establishing the safety and efficacy
of efficacious therapeutic interventions developed for adult populations in children” and addresses an urgent
need to prevent youth suicide during the high-risk post-discharge period. This intervention is scalable for
widespread use and has potential for high impact to prevent youth suicide.

Public health relevance
Project Narrative / Public Health Relevance Statement Suicide is the third leading cause of death among youth ages 12 to 17 in the United States, and emergency department visits by youth for suicidal thoughts or behaviors are increasing over time. There is a critical need to implement evidence-based interventions to prevent youth suicide during the high-risk period after an emergency department visit. To fill this gap, this study will determine the feasibility and acceptability of delivering Caring Contacts (brief messages of care and concern) via text message to adolescents with suicidal thoughts or behaviors after an emergency department visit to reduce suicide risk.